Southern New England Partnership In Stroke Research, Innovation and Treatment (SPIRIT)

We propose the Southern New England Partnership In Stroke Research, Innovation and Treatment (SPIRIT), a
StrokeNet Regional Coordinating Center (RCC) anchored by 3 leading institutions: Yale School of Medicine, the
Warren Alpert School of Medicine at Brown University, and Hartford Hospital. Each Hub is a Comprehensive
Stroke Center with 14 total Primary Stroke Centers. Yale is the 7th largest hospital in the United States, and in
collaboration with Brown and Hartford Hospital, and their respective networks, SPIRIT captures a diverse
geographic area that provides access to 5.7 million people, including most adult and pediatric stroke patients in
Connecticut and Rhode Island. This robust patient volume (over 3500 total stroke patients in 2016), combined
with an exceptionally strong collaborative and organizational framework, gives SPIRIT great potential for clinical
trial implementation. Principal Investigators Dr. Kevin N. Sheth (Yale), Dr. Karen Furie (Brown), and Dr. Mark
Alberts (Hartford Hospital) bring a complementary set of leadership and high-level clinical trials experience in
stroke. Each leader brings well recognized expertise in international multicenter studies and implementation of
stroke systems of care, as well as a track record of high quality stroke trial recruitment and retention. In various
capacities, they have worked together for over 12 years, and each PI leads an enthusiastic cadre of faculty
across disciplines, to create a highly collaborative environment focused on stroke research, multicenter trials,
membership on Institutional Review Boards, clinical trial committees, and extensive mentoring in patient-oriented
research. SPIRIT maintains strong connections to NIH funded CTSA networks and is further strengthened by
the following characteristics: 1) A pool of talented investigators with nationally recognized clinical and
translational research expertise in stroke; 2) Rich diversity (both ethnic/racial as well as urban/rural) of patients
in Southern New England currently not captured by the existing StrokeNet network; 3) Active leadership and
participation in stroke communities and stroke systems of care in the areas of statewide policy, continuity of care,
American Heart Association collaborations and regional education; 4) Deep investigator and patient pools for all
three areas of StrokeNet initiatives – prevention, acute treatment, and recovery; 5) Access to a range of
specialized tools already harmonized across centers including a common electronic medical record system
(EPIC) and RAPID software for acute stroke imaging, enhancing data sharing and collaboration; 6) Continuous
commitment from all three institutions to the central IRB model and use of a Master Trial Agreement; 7) Rich
science core with ongoing NIH funded stroke studies and multiple, active StrokeNet proposals currently under
review; and 8) An education core designed to identify, support and accelerate the development of tomorrow's
stroke investigators. The Yale, Brown, and Hartford stroke teams together – where the sum of the collaboration
is even more exciting than each part – is poised to make significant contributions to enhance and further the
mission of NINDS and StrokeNet to reduce the burden of neurological disease.

Public health relevance
Stroke is a leading cause of death and disability around the world. StrokeNet is the most exciting network in the world for identifying, nurturing and advancing therapies for stroke. The three-pronged approach to stroke – prevention, acute treatment, and recovery – searches for clinical trial concepts across the entire spectrum of disease. The SPIRIT Regional Coordinating Center represents a significant historic collaboration anchored by three leading academic medical centers. SPIRIT will bring to StrokeNet a new and large patient population, rich in ethnic and racial diversity, led by investigators with considerable experience in stroke trials implementation. SPIRIT will serve our community, train the next generation of academic stroke leaders, and in doing so, this work directly serves the NINDS mission to reduce the burden of stroke.